Interpericyte tunneling nanotubes as new therapeutic targets for neurovascular recovery and vision restoration in glaucoma.

PROJECT SUMMARY
Glaucoma patients suffer from major vascular deficits, but the mechanisms underlying blood flow abnormalities,
and whether they can be reversed, are not known. Our long-term goal is to develop innovative strategies that
promote neurovascular health and restore vision in glaucoma. The primary objective of this proposal is to
determine the mechanisms leading to glaucoma-induced damage of interpericyte tunneling nanotubes (IPTNTs),
highly specialized structures that connect two pericytes and are essential for blood flow regulation in the retina
and optic nerve. The central hypothesis is that signals from the microenvironment, notably surrounding glia
and retinal ganglion cells, act on IPTNT-linked pericytes to modulate calcium dynamics and blood flow; and that
disruption of these pathways cause vascular abnormalities in glaucoma. The rationale underlying this proposal
is that completion will identify key molecular targets for protecting or regenerating IPTNTs, which will improve
blood supply and support neuronal function. The proposed work will also develop a widely-applicable live imaging
platform to gain unique insights into how vascular defects affect retinal ganglion cell function during
glaucomatous stress. Our central hypothesis will be tested by pursuing three specific aims: 1) determine the
role of glia-derived S100β in IPTNT damage; 2) determine whether dysregulated adenosine signaling in neurons
and/or glia disrupts IPTNT-mediated capillary dynamics; 3) establish the efficacy of platelet-derived growth factor
BB as a strategy to regenerate IPTNTs. We will pursue these aims using well-established glaucoma models in
mice (aims 1-3) and non-human primates (aim 3) as well as an innovative combination of cellular, genetic, and
molecular tools with cutting-edge live imaging technologies using clinically relevant endpoints. The proposed
research is significant because it will determine the critical mechanisms that support IPTNT structure and
function and, therefore, have potential as therapeutic targets for glaucoma. It is also significant because using
both mice and non-human primates will generate rigorous and compelling pre-clinical data that will serve as a
knowledge-translation springboard for clinical development. This work will also develop foundational resources
that may be used by other glaucoma researchers. The expected outcome of this work is a better understanding
of the molecular underpinnings of blood flow insufficiency in glaucoma. The results will have an important
positive impact because they will identify molecular targets for further clinical development thus expanding
treatment options for glaucoma and other neurodegenerative diseases associated with vascular deficits.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will provide new insights into fundamental mechanisms underlying vascular deficits in glaucoma. Building on our recent discovery of nanostructures that regulate retinal blood flow, we propose to integrate cellular, imaging, and functional tools to uncover the molecular processes responsible for blood flow loss. The outcome of this research program is expected to give rise to novel treatments that improve blood supply and enhance neuronal function, a requisite for vision restoration in glaucoma.